U-RISE at Fort Lewis College

ABSTRACT
Fort Lewis College (FLC) is requesting funding for the Fort Lewis College NIH-URISE program that will support
15 new URISE scholars from June 1, 2021, to May 31, 2026. The long-term goal of this proposal is to provide
the foundation for a sustainable biomedical and behavioral (B&B) research training program that will more than
double the number of underrepresented (UR) students graduating with a STEM degree and pursuing a Ph.D.
in B&B research. This goal will be achieved by the following: 1) Increase the pool of URISE-eligible applicants
from 9 students to 20 students who enroll in course work, participate in workshops, attend seminars and
interact with outside speakers to ensure that URISE scholars are prepared for graduate school by 2026; 2)
Institute programs and initiatives that foster and promote the development and preparation of well-trained
biomedical scientists that have the technical and operational skills for post-graduate success; 3) Select 3
URISE scholars per year from the URISE-eligible pool; 4) 100% (15 or 15) of URISE scholars will graduate by
2026 and 5) 70% (10 of 15) of URISE scholars will matriculate to Ph.D. programs in B&B research within three
years of graduating from the URISE program. During the 2021-2026 funding cycle, URISE scholars will be
selected from students who are majoring in chemistry, biochemistry, biology, psychology, health sciences,
physics, and engineering. URISE scholars will complete the core requirements for their major, extramural
activities, workshops, and additional coursework. Extramural activities and workshops are focused on graduate
school preparation, including responsible conduct of research, enhancing reproducibility, professional skills,
and financial literacy. URISE scholars will receive extensive career and graduate school advising and will be
provided with numerous opportunities to enhance their written and oral communication skills. Opportunities will
be provided for URISE scholars to help build a strong cohort of STEM scholars through social and cultural
activities. Most importantly, URISE scholars will receive extensive year-round research training both at FLC
with their faculty mentors and through a summer research experience at a research-intensive institution. The
Provost of the college will provide institutional oversight. The Program Director (PD), and a Program
Coordinator (PC) will administer and manage the program. The PD, a Steering Committee and the Advisory
Council will oversee the program. FLC ranks first in the nation in percent of enrolled full-time, AI/AN
undergraduates and first in the nation in percent of degrees conferred to AI/AN students at public, non-tribal
colleges. Moreover, underrepresented minority students (AI/AN, Hispanics, African Americans, Native
Hawaiians and other Pacific Islanders) comprise 53% of FLC’s total 2019 population. With continued NIH
funding, FLC is uniquely positioned to significantly increase the number of underrepresented students,
especially AI/NA and Hispanic students, entering doctoral training programs in B&B sciences.

Public health relevance
PROJECT NARRATIVE Diversity in science and research is important in meeting the health needs of the nation. The long-term goal of this proposal is to maintain a sustainable biomedical and behavioral research training program that will more than double the number of underrepresented (UR) students graduating with a STEM (Science, Technology, Engineering and Math) degree and pursuing a Ph.D. in biomedical or behavioral research. This goal will be achieved by providing UR students an increased awareness of graduate research, by better preparing UR students to enter Ph.D. granting programs, and by graduating and enrolling more UR students in Ph.D. granting programs.